ENHANCING GLOBAL CANCER REGISTRY-CENTERED SURVEILLANCE (GLOBAL CR-CS) PROJECT

The purpose of this Global Cancer Registry-Centered Surveillance Task Order is to:

1. Build and enhance relationships with cancer surveillance organizations worldwide, improve the availability of good global cancer registry-centered surveillance data, strengthen regional cancer surveillance networks, and improve resource sharing among high quality cancer surveillance systems tailored to limited resource environments.
2. Facilitate communications and knowledge transfer through NAACCR members, NAACCR staff, and consultants in the use of technical resources which build on existing PBCR expertise and assets to provide direct and tangible benefits for limited resource countries. Priority shall be given to countries with strong interest and political commitment but unrealized action towards their potential for developing public health data systems with a focus on cancer surveillance.
3. Coordinate engagement and provide relevant education materials and training tools as a platform for building capacity and enhancing cancer registry-centered surveillance in resource-limited countries.